DEEPHIPPO: Ultra-thin lensless endoscope for the visualization of deep hippocampus neuronal functional activity.

Rigneault Project Abstract DEEPHIPPO DEEPHIPPO: Ultra‐thin lensless endoscope for the visualization of deep hippocampus neuronal functional activity. Principal investigator: Hervé Rigneault Host Institution: Aix‐Marseille University, Marseille, France Project duration : 24 months Project Abstract DEEPHIPPO breaks the experimental limitations of in vivo two‐photon calcium imaging in the deep brain where multiphoton (2photon and 3photon) microscopy is impossible. Using innovative multicore optical fibers together with wavefront shaping DEEPHIPPO aims at developing a novel and disruptive 2photon endoscope technology featuring a distal diameter as small as the fiber diameter. The technology will be validated to record neural activity either in CA1 or CA3 in freely moving mice. Addressing this timely biological question provides the drive for a tool development that will obviously pave the way to image deep brain structures in behaving animal models. 1

Public health relevance
Rigneault Project Narrative DEEPHIPPO DEEPHIPPO: Ultra‐thin lensless endoscope for the visualization of deep hippocampus neuronal functional activity. Principal investigator: Hervé Rigneault Host Institution: Aix‐Marseille University, Marseille, France Project duration : 24 months PROJECT NARRATIVE DEEPHIPPO aims at moving a step forward in deep brain imaging by developing a 2PE ultra‐thin lensless endoscopy, featuring diameters ranging from 150um to 300um, compatible with freely moving experiments. We will validate this disruptive technology in mouse brains to image in vivo the activity pattern of CA1 and CA3, in a minimally invasive manner. The developed technology will pave the way to image deep brain structures in living animal models. 1